Translational Light-Based Intervention Strategies for Improving Sleep and Circadian Health in Early Childhood

PROJECT SUMMARY/ABSTRACT
Evening sleep problems are prevalent in early childhood and increase the risk for poor behavioral and health
outcomes. Sleep is regulated in part by the timing of the circadian clock. Light is the primary zeitgeber (time cue)
of the circadian system, and evening light exposure can suppress production of the sleep-promoting hormone
melatonin and delay circadian timing, resulting in increased alertness and delayed ability to sleep. This K01
research project will examine the feasibility and preliminary efficacy of two evening light mitigation strategies to
advance the timing of sleep and the circadian clock in children. Central to this research is accumulating evidence
indicating high sensitivity of the early circadian system to light exposure in the hour before bedtime, even at low
intensities. To date, however, research is lacking on light-based circadian health interventions in early childhood
to improve sleep timing and behaviors.
Children aged 5.0-6.9 years with parent-reported sleep onset difficulties will complete a single five-week protocol.
After baseline assessments of circadian timing (dim-light melatonin onset), sleep timing, duration, and quality
(actigraphy), and parent-reported sleep behaviors, children will be randomly assigned to one of three two-week
intervention strategies: (1) adjustment to home lighting environment (implementation of smart lightbulbs to
reduce short-wavelength light and light intensity 1 h before bedtime); (2) reduction in evening light exposure
(amber-tinted glasses 1 h before bedtime); or (3) a sham intervention (clear glasses 1 h before bedtime). Post-
intervention, a secondary assessment of all outcomes will be performed, as well as qualitative interviews with
parents. These data will be used to examine the feasibility and acceptability of the intervention components
(Aim 1), their preliminary efficacy in advancing children’s sleep and circadian timing (Aim 2), and whether
individual differences in photosensitivity (assessed via pupillometry) moderate the response to the intervention
strategies (Exploratory Aim 3).
In addition to these research aims, this K01 award will incorporate training in four interdisciplinary areas: clinical
and translational science, designing and implementing interventions with young children, advanced methods in
photometry and photosensitivity, and biostatistics and professional development. The research and training
proposed will provide preliminary data for a competitive R01 application and be an important step in facilitating
Dr. Hartstein’s transition into an independent scientist with a research program committed to examining
modifiable environmental and behavioral factors affecting children’s sleep and circadian health.

Public health relevance
PROJECT NARRATIVE With children’s ever-growing use of light-emitting devices and evening exposure to artificial lighting, there is a crucial need to develop novel environmental and behavioral strategies to enhance sleep health in early childhood, a time when behavioral sleep problems commonly first emerge, increasing the risk for poor health outcomes. Informed by accumulating evidence indicating high sensitivity of the early circadian system to evening light exposure, this K01 research project will examine the feasibility, acceptability, and preliminary efficacy of evening light mitigation strategies to advance sleep and circadian timing in children with sleep onset difficulties. I anticipate these findings will be a first step in developing and testing a full-scale circadian intervention for young children, with the goal of improving early sleep health and well-being.